A hypercholesterolemia-induced immunometabolite in atherosclerosis

PROJECT ABSTRACT
A maladaptive inflammatory response to lipid imbalance underlies the chronic vascular inflammation in
atherosclerosis. Persistent activation of the Integrated Stress Response (ISR) signaling is also observed in both
mouse and human atheroma. ISR is an elaborate, homeostatic signaling activated by a range of conditions such
as hypoxia, hyperlipidemia and endoplasmic reticulum (ER) and mitochondrial stress, which are known to
promote atherosclerosis. Small molecules and genetic models that prevent hypercholesterolemia-induced ISR
signaling were shown to prevent atherosclerosis progression, demonstrating ISR’s causality in atherosclerosis
development. Despite regulating lipid-induced sterile inflammation, thereby representing a novel therapeutic
opportunity in cardiovascular disease (CVD), therapeutic targeting of a homeostatic pathway such as ISR in a
chronic disease is not without its challenges. Deciphering the detailed mechanisms by which ISR governs
macrophage immunometabolism and atherogenesis can pave the way to effective and specific therapeutic
strategies in CVD while escaping toxicity that may be associated with targeting homeostatic signaling. We made
the striking discovery that ISR inhibition in hypercholesterolemic mice leads to increased 5-
hydroxymethylcytosine (5-hmC) to 5-methylcytosine (5-mC) ratio in macrophages and plaques while reducing
IL-1b and atherosclerosis progression. The oxidation of 5-mC to 5-hmC is catalyzed by Ten eleven translocation
(TET) family of methylcytosine dioxygenases, somatic mutations in which are associated with coronary heart
disease and early-onset myocardial infarction (MI). The inactivation of TET-2 in mice promotes atherosclerosis
progression and cardiac dysfunction. Our robust preliminary data shows that hypercholesterolemia induces 2-
hydroxyglutarate (2HG), a potent TET inhibitory metabolite, in an ISR-dependent manner. Furthermore,
supplementation with a-ketoglutarate (aKG), a cofactor for TET, stimulates TET activity while inhibiting IL-1b
secretion in mouse and human macrophages. aKG supplementation in a small group of hypercholesterolemic
mice prevented inflammation while reversing TET inhibition. Building on the insight gained through our robust
preliminary studies and incorporating additional evidence from literature, we hypothesize that hyperlipidemia-
induced ISR signaling generates an immunometabolite that can promote macrophage inflammatory
response and atherosclerosis. We propose to investigate ATF4’s role in regulating macrophage
immunometabolism and promoting atherosclerosis in vivo. We will also investigate the consequences of
modulating 2HG levels in myeloid cells on inflammation and atherosclerosis in hypercholesterolemic mice. The
completion of the proposed studies will illuminate the metabolic and epigenetic consequences for ISR signaling
in macrophages on sterile inflammation and atherosclerosis development. The new knowledge gained through
these studies could pave the way for the development of effective and specific therapeutic strategies to
antagonize ISR signaling components that promote sterile inflammation and drive atherosclerosis progression.

Public health relevance
NARRATIVE Metabolites serve as powerful inter-organelle signaling molecules that modify the epigenome and have attracted great attention as both the mediators of tumorogenesis and novel therapeutic targets in cancer. We will investigate the impact of a hypercholesterolemia-induced metabolite, 2-hydroxyglutarate, in macrophages and its role in inflammation and atherogenesis. Our work will specifically provide insight into the pathways leading to hypercholesterolemia-induced production of 2-hydroxyglutarate and its epigenetic inflammatory targets in macrophages while investigating novel therapeutic opportunities in atherosclerosis through targeting this immunemetabolite.